Chemistry-enabled glycoscience

ABSTRACT - “Chemistry-Enabled Glycoscience”
Overall changes in glycosylation are associated with many human diseases. Cancer cells increase the levels
of speciﬁc capping sugars on their surfaces, while levels of the intracellular glycan O-GlcNAc are lower in
Alzheimer's disease. Some of these associative changes are being exploited as potential therapies. However,
a deeper understanding of what glycosylation is doing to the biochemistry and function of the underlying
proteins is still largely lacking. For example, thousands of proteins are modiﬁed by O-GlcNAc but the eﬀects
of the vast majority of these modiﬁcations are completely unknown. For several reasons - heterogeneity,
multiple modiﬁcation sites, low immunogenicity, etc. - traditional biological tools have limitations for
glycosylation. We have built a research program centered around the development and application of
chemistry-enabled approaches aimed at unanswered questions in glycoscience. For example, we have
played an important role improving and applying bioorthogonal reporters of glycans in living systems. We are
also leaders in the application of protein synthesis to generate site-speciﬁcally glycosylated proteins for for in
vitro and even in vivo characterization. We plan to build upon these successes to a) generate and apply cell/
tissue-selective reporters and inhibitors of glycosylation, b) create activity based probes of monosaccharide
biosynthesis, c & d) further understand the eﬀects of O-GlcNAc on pathogenic protein-aggregation, and e)
investigate the consequences of mucin glycans on apolipoproteins. In the next ﬁve years, we will have
created and used new tools for glycoscience in living systems and further unraveled the mechanisms by
which glycosylation changes the biology of important proteins in human diseases.

Public health relevance
NARRATIVE - “Chemistry-Enabled Glycoscience” Changes in glycosylation, the addition of carbohydrates to proteins, are associated with many human diseases, but the speciﬁc glycoproteins involved and how these changes aﬀect the biology of the underlying proteins are still very under-characterized. The overall goal of this research program is to apply a variety of enabling chemical-techniques - bioorthogonal chemistry, covalent inhibition, protein synthesis, etc. - to answer these key questions and develop new tools and approaches for the glycoscience community.